Improving multi-step planning in aging by overcoming deficits in memory encoding

Project Summary/Abstract
The objective of this R21 proposal is to investigate the behavioral and neural signatures of age-related decline
in memory function in service of multi-step planning. We anticipate that the results obtained here will serve as
preliminary findings in support of a research program using neuroimaging to evaluate how these circuits are
altered in diseases of aging, such as Alzheimer's Disease and Mild Cognitive Impairment (MCI).
Previous research into decision-making in aging has focused primarily on tasks that involve repeated
reinforcement of specific actions or stimuli (e.g. sequential reinforcement learning tasks), or on comparisons
between items whose values are directly instructed (e.g. gambles). A separate form of decisions, arguably
more germane to everyday experience, are those in which choices depend on planning: searching through
disparate events from our past experience, and reassembling them to achieve new goals introduced in the
moment (e.g. seeking an ice cream store you may have passed by but never entered).
These types of decisions, in addition to being relatively under-studied in older adults, are also distinct in
that they depend on long-term, episodic memory. Episodic memory is known to decline in age. A specific
aspect of episodic memory that is known to decline with age is the computation called pattern separation: the
ability to create divergent neural patterns that reflect inputs with similar or overlapping sensory features (e.g.
two flavors of ice cream). Pattern separation allows us to rapidly retrieve and re-use information even in the
face of interference. We can measure pattern separation in behavior using the Mnemonic Similarity Task
(MST), a short, widely used assay that predicts cognitive and neural deficits across the lifespan.
While we know that pattern separation and planning both decline with age, and we know that both
functions are supported by the same neural structures in healthy adults, we do not know if they co-exist in the
same neural circuits, nor do we know if a decline in pattern separation yields a decline in planning ability.
Here, we aim to fill this gap in knowledge, examining (Aim 1) the ability of older adults to construct
multi-step plans, and how it corresponds to pattern separation; (Aim 2) to further ask whether taking account of
an individual’s decline in pattern separation can allow us to structure their experiences in a way that improves
their ability to later construct plans on the basis of those experiences; (Aim 3) whether neural circuits for
pattern separation and planning overlap, and how they interact in normal cognitive aging. In sum, the proposed
research will determine whether we can improve individual decision-making by taking account of individual
differences in memory function; the findings will inform research into early detection and treatment of a wide
range of diseases of aging.

Public health relevance
Project Narrative This R21 proposal examines how decision failures in older adults can be explained by memory failures - and whether taking account of memory decline can improve decision-making. We use a behavioral task that examines how subjects learn individual elements of a multi-step plan, then later reassemble those elements on demand. The findings of this investigation will result in new behavioral and biomarkers of declines in cognitive function that are predictive of Alzheimers disease and related disorders.